Amazonian Center of Excellence in Malaria Research

PROJECT SUMMARY
Both the innate and acquired immunity play important roles on systemic inflammation and pathogenesis of
malaria as well as host resistance to Plasmodium infection. When patients are symptomatic with disease, they
generally seek curative therapy, thus interrupting potential transmission. In contrast, individuals with
asymptomatic disease, at least in theory, remain as reservoirs of disease. In this project, we will address
questions related to the innate and acquired immune responses that are relevant to understanding the
emergence and persistence of asymptomatic malaria individuals. Our previous epidemiological studies in the
Amazon suggest that multiple malaria infections result in substantial immunity, which is able to control, but not
eliminate malaria infection. In contrast to the acutely ill patients, the malaria immune individuals do not display
systemic inflammation and signs of disease. Our overall hypothesis is that innate immune cells from
individuals with low and persistent parasitemia, become hyporesponsive to Plasmodium stimulation
preventing systemic inflammation, but at the same time being unable to promote an acquired immune
response that is efficient in eliminating infection. We believe that despite the low levels of parasitemia, and
the predicted low rate of transmission per mosquito bite, such patients continue to be infective over long
periods of time and hence represent a silent barrier to efforts to eliminate malaria in the Amazon. In this
project, we propose to compare the innate and acquire immune responses elicited by Plasmodium infection in
acutely ill and asymptomatic patients, and to define mechanisms that are potentially involved in modulating the
systemic inflammation and preventing parasite elimination in asymptomatic malaria patients. Our first aim is to
compare the inflammatory response and responsiveness of innate immune cells from clinically ill and
asymptomatic malaria patients. In the second aim we will compare the development of humoral and cellular
acquired immune responses as well as immunoregulatory mechanisms that may influence hyper and hypo
innate immune responses in patients undergoing acute versus asymptomatic P. vivax or P. falciparum
infection. Finally, in Aim 3 we will investigate in longitudinal studies, various immunological, parasitological and
clinical parameters in patients with recurrent infection. We intend to validate the biomarkers defined in Aims 1
and 2, and to interrogate whether asymptomatic patients are prone to develop no diseases in recurrent
infections. We will also search for immunological correlates of infectivity of symptomatic and asymptomatic P.
vivax parasitemics for colonized An. darlingi mosquitoes. Outcomes of these experiments will identify innate
immune biomarkers as well as B and T cell responses that are predictive of disease outcome and mosquito
transmission. If successful, our studies will provide important information for monitoring silent infection in
infective asymptomatic individuals and potentially new insights to further control malaria transmission in hypo-
endemic areas.